Identifying Intermolecular Constraints on Influenza Virus Evolution

PROJECT SUMMARY/ABSTRACT
The long-term goals of the candidate are to establish an independent research laboratory investigating host
adaptation of zoonotic viruses. This proposal outlines a set of aims that will provide a foundation for a career as
a professor at an academic institution. The candidate has established a training plan comprising five main areas:
coursework in computational biology, mentorship under a diverse and supportive network of University of
Pittsburgh faculty, publication of research in peer-reviewed articles, networking at seminars and conferences,
and application for transitional funding and faculty positions. The candidate has assembled a diverse mentoring
committee to achieve these goals: Dr. Seema Lakdawala, the primary sponsor; Dr. Vaughn Cooper, co-sponsor
of this application; Dr. Erik Wright, collaborator; and a formal mentoring committee including Drs. John Williams,
Neal DeLuca, Matthew Nicotra, and Anne-Ruxandra Carvunis. See co-sponsor statement and letters of support.
The research objectives proposed in this application include the investigation of the role of complex
interactions on influenza virus evolution. Protein-protein interactions determine whether polymerase subunits are
compatible, and recently described RNA-RNA interactions are theorized to drive genomic assembly of viral RNA
segments into daughter viruses. However, the impact of such complex interactions on viral evolution are not well
understood. Such knowledge will ultimately aid in the prediction of how genetic reassortment of genomic
segments occurs between two influenza virus strains, a process that leads to emerging pandemic and zoonotic
strains. These objectives are in accordance with the mission of the NIAID to better understand and prevent
infectious diseases. We hypothesize that evolutionary relationships predict complex interactions among
viral RNA and protein that constrain reassortment. We present the following aims to address this hypothesis:
Aim 1. To define the mechanism of evolutionary constraints on RNA-RNA interactions in seasonal
human IAV. We will identify nucleotide residues underlying our initial observation that parallel evolution
occurs between viral RNA and examine their roles in genomic packaging.
Aim 2. To examine parallel evolution between protein subunits of avian polymerase complexes. We
will test whether complex protein-protein interactions similarly constrain avian influenza virus evolution.
These aims will provide a basis for the candidate to launch an independent laboratory distinct from that of her
advisor investigating evolutionary constraints on host adaptation of zoonotic viruses. The sponsor, co-sponsor
collaborator and mentoring committee are all present at the University of Pittsburgh and can provide the support
necessary for this candidate to succeed.

Public health relevance
PROJECT NARRATIVE This research will reveal the constraints imposed on influenza virus evolution by complex interactions between viral RNA and proteins. Such knowledge will allow public health officials to devise better strategies to prepare for emerging zoonotic influenza viruses. Thus, this research could lead to significant breakthroughs in reducing the global burden of zoonotic influenza viruses.